Accessing the hidden biosynthetic capabilities of fungi

PROJECT SUMMARY
Filamentous fungi are a major source of valuable natural products (e.g. antibacterial penicillin, the
immunosuppressant cyclosporin, the cholesterol-lowering drug lovastatin, the fungicide azoxystrobin and the
pesticide paraherquamide). Yet despite progress in genomic sequencing and the characterization of large
numbers of fungal NPs, the identification of small molecules with genuinely new structures and activities has not
kept pace with genome sequence. These key gaps are a consequence of current bioinformatic and genome
mining procedures which are biased towards locating well-characterized classes of NPs, which follow the
assumption that all genes important for synthesis of any particular NP will be clustered and lack consideration of
how fungal ecology can inform chemical synthesis. We have addressed these challenges by developing the first
genome-mining pipeline capable of identifying the new widespread chemical class of natural products in fungi,
the isocyanides and uncovering the unexpected role of copper in regulating both isocyanide synthase (ICS)
biosynthetic gene cluster (BGC) expression and compound production. To continue these advances, here we
focus on three key areas of investigation including (i) elucidating products of ICS BGCs containing genes
encoding unusual enzymatic features unique chemistries and/or target proteins, (ii) examining the hypothesis
that isocyanides direct microbiome composition dependent on metal concentrations and (iii) exploring the
potential of computational innovation to significantly advance an understanding of the foundations of fungal NP
logic. Overall, this work will advance the field of NP discovery in new directions that includes promoting the
chemistry and ecology of the poorly understood isocyanide NPs, dissecting consequences of NP elaboration on
microbiome composition and aligning molecular and chemical proficiencies with computational innovations for
uncharted NP discovery routes. Using molecular, chemical, ecological and computational tools, we are poised
to uncover fundamental questions in complex fungal networks governing NP synthesis. Better understanding of
these mechanisms is critical to elucidating NP classes with specific biological roles and, ultimately, to provide
knowledge to address escalating direct and indirect challenges confronting human health worldwide.

Public health relevance
PROJECT NARRATIVE Fungal natural products or secondary metabolites (SMs) have been invaluable as platforms for developing front- line drugs. Many SMs have been difficult to characterize due to a lack appropriate technological tools. This work will advance methods for discovery of useful SMs and provide a functional blueprint for identifying useful fungal SMs.